Neuroendocrine control of TLR4-dependent inflammation in influenza

SUMMARY
Influenza is a highly contagious respiratory illness that the CDC has estimated to afflict ~47.5 million
Americans with up to 62,00 deaths from October 1, 2019 to April 4, 2020. In the absence of a “universal
influenza vaccine,” yearly vaccination is strongly recommended; however, the composition of each vaccine is
based on predictions of which strains will predominate in the following year and such predictions may be
incorrect. Approved antivirals can ameliorate disease by limiting viral replication, but they must be administered
early in infection to be effective, and resistant influenza strains have emerged. While influenza-induced disease
is initiated by viral replication resulting in airway epithelial damage, the severe inflammatory response that
follows as a result of metabolic stress in innate immune cells (e.g., macrophages) ultimately elicits a “cytokine
storm” that may lead to acute respiratory distress syndrome (ARDS) and death. Thus, a new approach that
targets the host innate immune response would represent a highly significant therapeutic advance for influenza
as well as other respiratory viruses that lead to ARDS, e.g., SARS-CoV-2. We have identified Toll-like receptor
4 (TLR4), a pattern recognition receptor best known for its ability to sense Gram-negative lipopolysaccharide
(LPS), as key to the host inflammatory response to influenza. This was initially surprising since influenza virus
does not express any “pathogen-associated molecular patterns” that trigger inflammation via TLR4.
Nonetheless, using both TLR4-/- mice and multiple TLR4 antagonists in both a mouse model of influenza
infection, as well as in cotton rats (Sigmodon hispidus; CR) that are susceptible to non-adapted strains of
human influenza, we rigorously demonstrated that TLR4 signaling is central to the generation of lung and
systemic inflammation in response to infection. We identified a host-derived protein, High Mobility Group Box-1
(HMGB1), released from dying cells during infection, that acts as a “danger-associated molecular pattern,”
thereby triggering TLR4 through its co-receptor, MD2. Recently, we identified a second host-derived protein,
gastrin-releasing peptide (GRP), as contributory to influenza-mediated disease, using three distinct inhibitors of
GRP or GRP receptor signaling to significantly blunt cytokine production, lung pathology, and lethality when
administered to mice therapeutically. Our published and preliminary data support the central hypothesis that
these two mediators are interrelated and converge during the host response to influenza infection. In two
Specific Aims, we propose to (1) delineate influenza-mediated interactions between GRP receptor (GRPR)-
and TLR4/MD2-mediated signaling, and (2) correlate GRP and HMGB1 levels with disease severity in two
distinct experimental models of influenza-induced disease and in influenza-infected patients. In this exploratory
R21 application, we shall seek to identify the mechanistic underpinnings of the relationship between these two
signaling pathways with the potential of identifying therapeutic strategies to ameliorate disease.

Public health relevance
LAY NARRATIVE Influenza, as well as other respiratory pathogens, induces host inflammatory responses that lead to acute lung injury, followed by disseminated inflammation, and ultimately death. This application focuses on defining specific mediators of this harmful pathogen-initiated process with the goal of identifying novel drugs that act against host- or pathogen-derived “danger” signals.